Mechanisms of treatment failure in chimeric antigen receptor T cell therapy

PROJECT SUMMARY / ABSTRACT
Adoptive immunotherapy with genetically modified T cells expressing a chimeric antigen receptor (CAR) is
highly promising for B-cell malignancies. However, fewer than half of patients with relapsed non-Hodgkin
lymphoma (NHL) achieve durable remissions following treatment with CD19-targeted CAR T cells. In some
cases this results from target antigen loss or rejection of the infused cells due to immunogenic murine CAR
components, but in most cases the causes of treatment resistance or relapse after an initial response remain
poorly understood. We propose a plan to elucidate the reasons for treatment failure in a recently initiated CAR
T cell clinical trial by carefully evaluating biological features of the tumor and tumor microenvironment before
and after CAR T cell therapy as well as phenotypes of patient T cells and infused CAR T cells.
As part of our phase I/II clinical trial of a fully human 3rd generation CD20-specific CAR in patients with
relapsed or refractory B-cell NHL (funded by a separate source), all patients undergo mandatory tumor
biopsies before and after treatment. This will allow us to discover biological characteristics predictive of
responsiveness to treatment, and to evaluate adaptive changes in the tumor over time to reveal the
mechanisms of immune escape leading to relapse. We will employ a step-wise approach using state-of-
the-art methodologies, including multicolor flow cytometry, single-cell RNA sequencing and gene expression
profiling, and multiplex immunohistochemistry. We have assembled a world class team of investigators that will
evaluate the potential obstacles to successful therapy, including tumor entry barriers, tumor infiltration by
suppressive cells, CAR T-cell exposure to inhibitory ligands or secreted proteins, and CAR T-cell exhaustion.
There is a robust body of preclinical data demonstrating that less-differentiated T cell subsets impart
superior in vivo expansion, persistence, and anti-tumor efficacy, compared with more differentiated T cell
subsets. Recent data from a small trial suggests that the frequency of these less-differentiated CD8+ cell
subsets before and after CAR T cell manufacturing correlates with clinical responses in patients with chronic
lymphocytic lymphoma receiving CD19-targeted CAR T cells. These results have important implications, but
must be validated in other settings. We will quantify less-differentiated T cell subtypes prior to leukapheresis,
as well as in the infused CAR T cell products, and correlate these characteristics with anti-tumor responses
and in vivo expansion and persistence.
We anticipate that these correlative studies will yield critical insights into the reasons why CAR T cell
therapy is successful for some NHL patients but not others. We are hopeful that our findings will help to guide
patient selection and counseling, and inform future strategies to overcome these obstacles through improved
cell manufacturing technologies, CAR vector design, and/or combinatorial adjuvant therapies, not only for
CD20-specific CAR T cells, but also for CAR T cell therapy for other targets.

Public health relevance
PROJECT NARRATIVE Patients with non-Hodgkin lymphoma (NHL) who relapse or have refractory disease have a poor prognosis with standard treatments, but immunotherapy using genetically modified T cells that recognize and kill lymphoma cells holds great promise. However, fewer than half of patients with relapsed NHL achieve durable complete remissions following treatment with chimeric antigen receptor (CAR) T cells, and the reasons for this are not understood. We propose a plan to discover why this treatment fails in many patients, using specimens collected in a recently initiated CAR T cell clinical trial, insights that will help to make this treatment more effective in the future.